C. albicans cell wall stress responses and TOR signaling

Abstract
Medical progress in many fields like oncology, transplantation, surgery, neonatology and rheumatology is
hurt by the rising incidence of invasive fungal infections. Developing novel antifungal therapeutics is
challenging because fungal and human cells share many homologous essential proteins. A novel approach
to antifungal development could be to target non-conserved domains within conserved proteins, following
detailed functional and structural characterization. On the other side, the cell wall has proven to be an
excellent target: it commands a significant portion of signaling- and metabolic resources of the fungal cell,
and the entire organelle is absent in humans. Identifying non-conserved regulatory elements in cell wall
stress endurance, and testing non-conserved protein regions to identify targets of domain-based drug
discovery, could expand the spectrum of targets for novel compounds that synergize with cell wall-active
agents and protect them from resistance development. Mutants in Candida albicans Target of Rapamycin
kinase 1 (Tor1) truncated for its least conserved region, N-terminal HEAT repeats, are hypersensitive to
cell wall stress. Among transcripts aberrantly regulated in Tor1 N-terminal truncation mutants are a cell
wall stress transcription factor and its putative regulator, both not present in humans. This transcription
factor mediates C. albicans responses to echinocandins, antifungal agents that inhibit biosynthesis of the
major structural polysaccharide in the fungal cell wall. We propose to identify targets in C. albicans cell
wall stress endurance, whose inhibition potentiates echinocandins and protects them from resistance
development, or has a cidal effect on its own. To this end, we will characterize a key cell wall stress
transcription factor and its regulator, and two non-conserved regions of Kog1, the essential regulator in
Target of Rapamycin Complex 1. Human oncologic target investigations and mechanistic analysis of
neurodegenerative diseases combined, provide important background understanding of domain-based
drug discovery and inhibitors of prion-like motifs. We intend to leverage this understanding towards a proof
of the principle, that the paradigm for antifungal drug discovery can expand beyond the biosynthetic
enzymes that currently are major targets, to include non-conserved regulatory elements which the fungus
needs to protect its cell wall.

Public health relevance
Narrative Antifungal drug development is challenged by the similarity of essential fungal and human proteins. We focus on non-conserved elements of Candida albicans Target of Rapamycin- and cell wall stress signaling. Our goal is to identify and characterize targets that are unique to the fungus and that represent critical functions when C. albicans confronts cell wall stress imposed by antifungal medications or by the host immune system.